Career Enhancement Program

ABSTRACT – Career Enhancement Program (CEP)
The Career Enhancement Program (CEP) plays an integral role in the Duke Brain SPORE by providing seed
support for pilot research projects with translational potential from promising new and early stage investigators.
Projects that are broadly collaborative both within and external to Duke; that test novel concepts and
paradigms that bring new approaches into the field; and that further expand the scope of the brain tumor
diagnosis, prevention, and management will be prioritized for support. The Specific Aims of the CEP are: 1)
Identify and support meritorious translational projects led by NIH-designated new or early stage investigators
that have a high probability of impacting the diagnosis, treatment or prevention of brain tumors; 2) Recruit and
retain promising women and minority new and early stage investigators with a career focus in translational
neuro-oncology research; 3) Facilitate access to programs for leadership training and a highly successful
program for grant writing that includes mentoring of new and early stage investigators to enable such faculty
members to achieve independent faculty status with emphasis on neuro-oncology research; and 4) Provide
continuing evaluation of progress on funded projects and facilitate their evolution into full SPORE projects or
independently funded projects. By developing the next generation of investigators and new lines of
investigation that can either replace projects within the SPORE or progress as independent, externally
supported research projects, the CEP plays a critical role advancing the Program's goal to overcome
limitations in malignant brain tumor therapies.

Public health relevance
PROJECT NARRATIVE – Career Enhancement Program The Career Enhancement Program is a critical component of the Duke SPORE in Brain Cancer and meets the NIH requirement for all SPOREs. It will take maximum advantage of new research opportunities in brain tumors, attract new outstanding investigators and collaborators to the field of neuro-oncology and, importantly, serve as a source of new translational projects for the SPORE. By attracting new investigators to the field of neuro-oncology research, this program will accelerate discovery and expand the breadth of research to improve outcomes for patients with primary brain tumors.